Mechanistic Assessment and Treatment of Immune Related Adverse Events

Immune related adverse events (irAEs) secondary to immune checkpoint blockade (ICB) or other
immunotherapies are a significant problem for Veterans and the general public given the increasing use of ICB
and other immunomodulatory agents. It is therefore of critical importance to improve understanding and optimize
treatment regimens for irAEs. Dermatologic toxicity is among the most frequent irAE and thus understanding
dermatologic irAEs is an immediately accessible window into the autoimmune pathology caused by ICB. Lessons
from skin irAEs thus can inform approaches to other irAEs. Our objective is to define the role and function of
resident memory T cells in skin irAEs due to anti-PD-1 monotherapy (pembrolizumab or nivolumab). As ICBs
and immunomodulation are increasingly used in other contexts, irAEs are inevitable and increasing in incidence.
Completion of the work here will further our goal to define the pathophysiologic mechanisms of
immunomodulator-induced adverse events and develop a precision medicine approach to ultimately facilitate
rational novel therapeutic strategies to improve efficacy and tolerability while preventing or rapidly mitigating
irAEs. Our central hypothesis is that CD8+ resident memory T cells are critical drivers of skin irAEs. These
hypotheses build both on our prior work to define molecular signatures of morphologically similar non-irAE skin
rashes, culminating in development of the rmAD43 and rmPV45 signatures, our analyses of public datasets on
ICB-induced irAEs, and our preliminary work on analyzing ICB-induced skin irAEs. We will test this hypothesis
using complementary approaches including innovative deep analysis of prospectively collected patient samples
and recapitulation and modulation of phenotypes using relevant mouse models. The work we propose here will
also develop an understanding of skin irAEs that will offer insights to determine pathways involved in immune
related adverse events in other organs and help identify predictive markers of these toxicities. Our team of
experts in immunology, immunotherapy, melanoma, skin biology, and bioinformatics will test this central
hypothesis and achieve our objective via the following specific aims: 1) Determine significance and profile of
CD8+ Trm cells in human skin irAE and 2) Define activity of IL-17A and its modulation in skin irAE using relevant
murine models. We will leverage our prior work in both single cell RNA sequencing and the DNFB mouse
dermatitis and NINJA mouse models in a highly innovative and integrative manner to determine both signatures
and mechanisms of cutaneous irAEs as well as identify and test rational therapeutic targets to mitigate these
side effects. The expected outcome is to provide insight into the mechanisms underlying skin irAE secondary to
ICB and a deeper understanding of associated pathways associated with skin-directed irAEs. We will also test
strategies to treat skin irAEs which can be rapidly translated for clinical utility. These results will allow us to further
develop evidence-based strategies for skin irAEs and will form the foundational basis for future clinical trials to
test hypotheses and improve therapeutic strategies for all irAEs and ultimately benefit Veterans health.

Public health relevance
The proposed project seeks to identify molecular changes in cutaneous immune-related adverse events (irAEs) due to immune checkpoint blockade (ICB) treatments for cancer and to utilize these patterns to develop a more precise approach to better understand and ultimately identify molecularly-targeted therapies to treat these irAEs while maintaining anti-tumor effect. We will utilize an innovative approach incorporating both single cell profiling of translational patient samples and novel mouse models to more precisely characterize these irAEs. This work is highly relevant to health given the use of ICB and other immunomodulatory treatments and the often difficult to treat and symptomatic nature of these irAEs.